Subcellular imaging of biochemical processes within human retina

DESCRIPTION (provided by applicant): Polgenix, Inc. is developing an imaging instrument, the 2-photon ophthalmoscope, or 2PO, with the capability for non-invasive, repetitive and high-resolution imaging of biochemical processes within human retina. This device will allow early detection of age- and disease- related changes in the eye, long before pathological manifestations of retinal disease become discernable by existing methods. Such real-time retinal imaging will also be critical for evaluation of various therapies for retinal pathology. Thus, patients susceptible to retinal disease could be diagnosed with 2PO and treated well before vision loss occurs. Once developed, the instrument will be used initially for ophthalmic drug screening and establishing objective biomarkers for retinal disease in animal models. Then it will be employed for clinical trials and ultimately for monitoring retinal health and the impact of therapy in patients. Early application of the device toward the development of effective ophthalmic therapies and clinical diagnosis will be leveraged through collaboration with experts in biochemical processes in the eye and high-resolution adaptive optics ophthalmic imaging from Case Western Reserve University and the University of Rochester, respectively. PUBLIC HEALTH RELEVANCE: We seek to develop a novel instrument for noninvasive imaging of the back of the eye with sub-cellular resolution. The instrument will visualize and quantify the age or disease related changes in the biochemical processes within human retina. Our goal is to further understanding of the biochemistry of vision and to enable rapid evaluation of the impact of therapeutic interventions aimed at retinal diseases at the earliest stages, before retina is damaged and vision is irreparably diminished.

Public health relevance
We seek to develop a novel instrument for noninvasive imaging of the back of the eye with sub-cellular resolution. The instrument will visualize and quantify the age or disease related changes in the biochemical processes within human retina. Our goal is to further understanding of the biochemistry of vision and to enable rapid evaluation of the impact of therapeutic interventions aimed at retinal diseases at the earliest stages, before retina is damaged and vision is irreparably diminished.